Chemistry Track III - Animal Food Product Testing

Chemistry Animal Food Product Testing Project Abstract The goal of this project is to assist Tennessee's Technical Service Laboratory (TSL) in maintaining conformance to the current AFRPS program and to adapt to any changes that the AFRPS program may see in the future. The TSL intends to conduct the proposed work using the equipment and staff outlined in this project. The TSL plans to continue offering current analyses that are accredited under ISO 17025 with the plan of adding more testing options during this cooperative agreement.

Public health relevance
Chemistry Animal Food Product Testing Research Narrative The Technical Services Laboratory (TSL) is Tennessee's regulatory lab for animal food and is the primary servicing lab for the Tennessee Department of Agriculture's (TDA) AFRPS program. The TSL plans to continue working to maintain conformance to the standards set forth in the current AFRPS program. The work outlined in this project will allow TSL to maintain its sampling agreement in line with conformance and adapt to any changes that may need to be addressed.